Creating Access to Resources and Economic Support (CARES)

Project Summary/Abstract
Transgender people experience economic and psychosocial inequities that make them
particularly vulnerable to COVID-19 pandemic-related financial and mental health harms.
Sustainable, multilevel interventions are needed to address these harms and promote COVID-
19 prevention behaviors. Transgender-led organizations have been galvanized to provide
emergency financial and peer support for transgender people negatively impacted by COVID-
19. However, the efficacy of these interventions have not been evaluated. Leveraging existing
community partnerships and ongoing cohorts, the study seeks to assess the efficacy of feasible,
acceptable, community-derived interventions to reduce economic and psychological harms
experienced by transgender people in the wake of COVID-19. The specific aims of the project
are to (1) compare the efficacy of microgrants with or without peer mentoring to reduce
psychological distress and increase COVID-19 prevention behaviors; (2) examine mechanisms
by which microgrants with or without peer mentoring may impact psychological distress; and (3)
explore transgender participants' intervention experiences and perceived efficacy. These aims
will be met by enrolling 360 transgender adults into an embedded, mixed methods, 3-arm, 12-
month randomized controlled trial. Participants will be randomized 1:1:1 to the following arms:
(a) a single microgrant plus monthly financial literacy education (usual care); (b) usual care plus
monthly microgrants; or (c) usual care plus monthly microgrants combined with peer mentoring.
All intervention arms will last for 6 months, and participants will complete semi-annual web-
based surveys at 0, 6, and 12 months as well as text-based process measures at 3 and 6
months to meet Aims 1 and 2. A subset of 36 participants, 12 per arm, will complete longitudinal
in depth interviews at 3 and 9 months to meet Aim 3. In addition to addressing the pressing
impacts of the COVID-19 pandemic on a vulnerable health disparities population, this study will
advance the science of minority stress and mental health inequities by testing interventions that
operate on general stressors – i.e., material hardship and community connection – rather than
minority stressors such as enacted stigma. This national, online study will address multilevel –
structural and community – factors driving COVID-19 pandemic harms. Its equitable community
partnership will ensure that study findings are actionable and disseminated rapidly to inform
sustainable community-based responses to the COVID-19 pandemic as well as future
emergencies.

Public health relevance
Creating Access to Resources and Economic Support (The CARES Study) Project Narrative Gender minorities are particularly vulnerable to COVID-19 pandemic-related economic and mental health harms. This health disparities population needs effective, sustainable, community- led interventions that address their unique needs. The goal of this study is to test the efficacy of a microgrant intervention with or without peer mentoring to reduce psychological distress and promote COVID-19 risk reduction behaviors.